Interdisciplinary Biomedical Imaging Training Program

The Interdisciplinary Biomedical Imaging Training Program will prepare predoctoral trainees to become leaders in organism-level biomedical imaging technology and application research. Multi-disciplinary teams of engineers, physicists, biologists, and clinicians are required to advance biomedical imaging, especially with the advent of in vivo cellular and molecular imaging. We will create the next generation of interdisciplinary biomedical imaging scientists and engineers who will contribute to and lead such teams. Our training program will build upon continuing, significant institutional, state, federal, and commercial investment in faculty and imaging infrastructure. A training grant award will place students squarely in the center of ongoing interdisciplinary/multi-disciplinary research programs. Trainees will use imaging facilities in the Case Center for Imaging Research, which includes state-of-the-art clinical and preclinical imaging systems, along with labs of mentoring faculty. Predoctoral trainees will be from the highly-rated departments of Biomedical Engineering and Physics, both of which have a long history of training in biomedical imaging. Trainees will conduct research projects combining enabling technologies in imaging with biomedical research. Each trainee will have two or more mentors representing both imaging technology and biological/clinical applications of imaging. Our educational program includes a portfolio of imaging courses, including ones focusing on imaging physics, image analysis, and reconstruction, as well as nanomedicine. We will promote a culture of interdisciplinary research during a designated Imaging Hour. In general, our T32 has helped make graduate students cost-effective as compared to postdocs and ensured training of domestic PhDs in this area of critical need. In less than nine years, our T32 program has already successfully trained several graduates, all of whom have exemplary training records and a trajectory towards success. Other trainees are moving through the program, focusing on exciting interdisciplinary imaging research, and with excellent research productivity.

Public health relevance
Relevance to Public Health. Biomedical imaging enables early disease detection, assessment of therapy, and minimally invasive treatment of disease. Especially with the advent of cellular and molecular imaging and machine/deep learning, biomedical imaging research requires persons with strong interdisciplinary training.